Food Protection Task Force meetings to foster communication, cooperation and collaboration within the State

Food Protection Task Force and Integrated Food Safety System Project Grant Program Funding Opportunity Number RFA-FD-16-039 Hueste, Eric-PI Project Summary/Abstract The annual meeting(s) of the Missouri Food Safety Task Force (FSTF) will offer educational opportunities in core areas and allow the members of the FSTF to collaborate and discuss food safety strategies first hand with industry, academia and fellow food safety professionals. Each meeting will provide a forum for all stakeholders to learn more about the food code and food safety; assist with adopting or implementing new food laws and rules; promote food defense/security and decrease the incidence of foodborne illnesses.

Public health relevance
Food Protection Task Force and Integrated Food Safety System Project Grant Program Funding Opportunity Number RFA-FD-16-039 Hueste, Eric-PI Project Narrative The Missouri Food Safety Task Force (FSTF) will host annual educational meeting(s). As with previous educational meetings and projects completed by the FSTF, the meeting(s) within this new grant period will continue to promote a more efficient statewide food safety/defense with the focus on prevention, intervention and response. The annual meeting will encourage regulators, industry, consumers and academia to work together for a more integrated food safety system.